Resource Core - A Carolina Center to Characterize and Maintain Mutant Mice

PROJECT SUMMARY
For decades, the mouse has been the premier animal model for studies of human disease, providing
the opportunity to explore experimental questions that are intractable for direct study in humans. As a
result, key mechanistic insights have been obtained for various clinical conditions to inform therapeutic
development. Spurred by advances in technology and international efforts to systematically knock out
all of the protein coding genes in the genome, the number of genetically engineered mice has
expanded rapidly in the past 20+ years. The responsibility for maintenance and distribution of mutant
mice was initially placed on individual investigators, which was a tremendous burden in terms of cost,
labor and space. In 1999, the NIH recognized the need for a resource to protect the investment in
mutant mouse strains and ensure open access to all biomedical researchers. It established the Mutant
Mouse Resource and Research Centers (MMRRC) to meet this need. Since 1999, the central goal of
the MMRRC-UNC has been to work collectively with MMRRC consortium partners to develop and
maintain high standards for importation, rederivation, cryopreservation, and distribution of mutant
mouse strains to biomedical investigators and incorporate research goals that synergize with and
extend the value of the resource. The MMRRC-UNC will continue contributing to these Consortium
goals by implementing the following Specific Aims in the next project period: 1) Streamline and
improve operating procedures to continue the efficient importation, distribution, and cryopreservation of
mouse strains created by investigators throughout the United States and beyond. 2) Support the
distribution and enhance the scientific value and long-term stability of the Collaborative Cross (CC)
resource. 3) Implement Genetic QC (GQC) procedures to enhance the rigor and reproducibility of
mouse models distributed by the MMRRC and advocate for their adoption across the biomedical
research community. 4) Investigate the interaction of genetics and environment on experimental
efficiency, variability, and reproducibility.

Public health relevance
PROJECT NARRATIVE Genetically engineered mouse models provide a tractable system for studying human development and disease, aiding discoveries that dramatically improve public health. The primary objective of the MMRRC-UNC is to import, archive and distribute mouse strains to the scientific community to provide efficient and open access to validated models and protect the investments made in their development. In addition, the MMRRC- UNC has developed synergistic research projects to support colony maintenance and enhance the rigor and reproducibility of biomedical research using mouse models.